IGF::OT::IGF PATHOLOGY PEER REVIEW AND PATHOLOGY SUPPORT FOR THE DNTP AND DIR AT NIEHS INTEGRATED LABORATORY SYSTEMS, INC. (ILS).

This contract provides The National Institute of Environmental Sciences and the Division of the National Toxicology Program (NIEHS/DNTP) with a wide variety of collaborative pathology services that best support the DNTP's evolving toxicologic research and chemical/agent testing mission. The services provided range from traditional GLP-compliant toxicologic pathology support and the conduct of the Pathology Peer Review (Quality Assessment and Pathology Working Groups Reviews) to the development and/or refinement of special pathology-based procedures and innovative technologies responsive to investigative research concerns and mechanistic issues. Because the DNTP's service needs are largely unpredictable, adequate numbers of DNTP-qualified and experienced pathologists, proficient technical personnel and support staff must be committed on an as-needed basis to be immediately responsive to the collective pathology requirements of eight individual task assignments, including several involving client-site services.